Development of A Directed Evolution Platform for RNA Methyltransferases.

PROJECT SUMMARY
N6-methyladenosine (m6A) is one of the most abundant chemical modifications in human messenger RNA
(mRNA). m6A in mRNA is dynamically regulated by the effector proteins that install, remove, and specifically
recognize m6A-modified transcripts, which are known as writers, erasers, and readers, respectively. Growing
evidence has suggested the significant roles of m6A in cancers including acute myeloid leukemia, endometrial
cancer, breast cancer, and glioblastoma. Dysregulations in m6A, its effector proteins, and related metabolites
have been shown to significantly influence the development of tumors, drug resistance, prognosis, and the
spread of cancer in various forms. However, understanding of the explicit roles of m6A in cancer biology remains
incomplete. Current efforts on understanding epitranscriptomic regulations heavily rely on altering the expression
of an effector protein, which typically generates global alterations to the modification levels on hundreds of mRNA
substrates and perturbs all other molecular interactions involving the effector protein beyond their roles in
regulating RNA modifications. With such convoluted results, it is challenging to deduce the explicit functions of
m6A on specific genes. To identify key regulatory m6A-modified transcripts in cancers, tools that enable efficient
and precise installation of m6A(s) at any one or multiple mRNAs of interest are highly desirable. One major
challenge is that the existing m6A writer or methyltransferases suffer from slow turnover rates, dependence upon
auxiliary proteins, and sequence biases of RNA substrates. Here we propose to develop a directed evolution
platform to evolve RNA MTases with improved catalytic efficiency and reduced substrate sequence recognition
biases. This directed evolution platform will leverage in vitro compartmentalization and m6A-specific
endoribonucleases to achieve rapid enrichments of functional MTase variants from a diverse (1010) library. The
evolved MTases will be further fused with RNA-targeting CRISPR-Cas systems to achieve site-specific
installation of m6A with high efficiency and reduced off-target editing.

Public health relevance
PROJECT NARRATIVE Growing evidence suggests that dysregulations in the RNA chemical modification landscapes strongly correlate with cancers. Tools that enable site-specific modulation of RNA modifications are critical to elucidate the function of RNA chemical modifications in biology and cancers; these tools provide basis for future development of genetic medicine targeting RNA chemical modifications. In this proposal, we aim to develop robust, efficient, and accurate editing tools for site-specifically installing the N6-methyladenosine on human mRNAs, via establishing a directed evolution platform to rapidly select high-performance N6-methyladenosine methyltransferases.